Mali ICEMR: Malaria Vector Ecology and Transmission Dynamics

SUMMARY
This project of the ICEMR focuses on the ecology of Anopheles malaria vector populations in Mali, West
Africa, where, as in most African countries, current vector control tools used inside houses are not sufficient to
achieve successful malaria control and local elimination. A better understanding of malaria vector and
transmission ecology is needed. Research on malaria vectors is typically done in villages because this is
where mosquitoes blood-feed on humans and transmit malaria parasites. Much less is known about how the
ecology of vectors beyond the periphery of villages affects transmission. Key gaps in outside-village ecology
that represent a major void in the understanding of transmission dynamics include: 1) sources and survival
strategies of vector populations during the long dry season; 2) how vector survival and transmission potential
are influenced by local environmental resources used for resting and sugar feeding; and 3) how recently-
discovered natural infections of Wolbachia in anopheline mosquitoes may impact transmission. Therefore, the
goal of this project is to investigate important neglected aspects of malaria vector and transmission field
ecology at four sites in Mali, representing three major eco-zones that span the sub-Saharan Sahel region.
Study sites are already well characterized with respect to vector populations, seasonal Plasmodium falciparum
transmission, and malaria epidemiology. This project, which builds on extensive preliminary studies in Mali,
includes three specific aims: 1) Evaluate how malaria vectors use limited natural and often cryptic habitats as
refugia during the dry season and how these habitats serve as the source for population expansion with the
onset of rains; 2) Determine how local environmental resources used for vector resting and sugar-feeding
behavior impact malaria parasite transmission dynamics; and 3) Investigate the prevalence of Wolbachia and
Plasmodium falciparum parasites in natural populations of the Anopheles gambiae complex in different
ecological settings and experimentally test how Wolbachia affects vector competence. Innovative aspects
include: First, preliminary results demonstrating isolated refugia along the River Niger, where during the dry
season high densities of Anopheles gambiae complex mosquitoes exist and actually feed predominantly on
birds, gives confidence that an integrated approach (ground searches, camera mounted drones, and satellite
imagery) can be used to identify and define cryptic dry season habitats that are sources of vector populations
during the dry season. Second, this is the first study to address the question of how vector sugar-feeding and
resting specifically on invasive and agricultural plants affects transmission. Third, this is the first longitudinal
ecological study of Wolbachia infecting malaria vector populations in Africa, and the first to examine how
Wolbachia infections impact vector competence. New insights how on vector ecology impacts transmission in
three eco-zones in Mali will provide field-based evidence needed for understanding how to overcome major
barriers to malaria elimination in West Africa.
!

Public health relevance
RELEVANCE This project focuses on important neglected aspects of malaria vector and transmission ecology at four sites in Mali, representing three eco-zones across West Africa. It addresses the need to better understand how anopheline mosquitoes survive during the long dry seasons, how mosquito resting and sugar-feeding behavior influence parasite transmission, and how malaria parasite development may be compromised in mosquitoes infected with bacterial endosymbionts. This field-based vector biology research will contribute to better understanding and development of more effective strategies to reduce malaria transmission in Africa. !